Career Enhancement Program

PROJECT SUMMARY/ABSTRACT
The overall Specific Aim of the Career Enhancement Program (CEP) is to recruit and develop the careers of
junior faculty members who are committed to translational research in prostate cancer, and, in well-justified
cases, mid-level and senior investigators who are already established in another area of research who want
to redirect their research focus to the field of prostate cancer.
The future of prostate cancer research lies in the continued entry of creative and innovative investigators
into the field and the development of basic and translational projects that solve areas of unmet need.
Institutional support of these endeavors is also critical to advances in the field; therefore the Prostate
SPORE's CEP is supplemented by institutional funds to allow for rapid funding of important new initiatives
within the scope of our SPORE research goals. Institutional funding has been secured for SPORE project
and core support, as well as to provide supplemental funds for the CEP budget, allowing for the SPORE
program to support promising new investigators working in the field of prostate cancer translational
research. The priority for funding will be those applicants with potential for an independent research career
in the field of prostate cancer, and whose initiatives are considered of highest scientific merit and with
translational potential and relevance to the overall research mission of the UCLA Prostate SPORE. After
initial review by the CEP Selection Committee, the Executive Committee approves the funding line and
determines priorities for use of the CEP funds. Annual funding for each project will be a minimum of
$25,000, with a goal of $50,000, and a minimum of two CEP awards will be funded annually.

Public health relevance
PROJECT NARRATIVE Prostate cancer is the most common cancer diagnosis and the second leading cause of cancer-related death in American men. The CEP plays a key role in recruiting and training exceptional scientific talent for translational research projects in prostate cancer.